Dopaminergic modulation in auditory decision-making

PROJECT SUMMARY
I propose to study the role of dopamine signaling within the neostriatum in the context of auditory-based decision-
making. Decision-making based on sensory perception is an integral part of everyday life and a cornerstone of
ones ability to respond to the environment with appropriate actions. This pivotal process is dysfunctional in
neuropsychiatric disorders such as Parkinson’s disease and schizophrenia. Studies demonstrate that the
neostriatum is a neural correlate for perception-based decision-making and that striatal neurotransmitter
imbalances can disrupt such behaviors. Our lab studies a caudal portion of the dorsal striatum—referred to as
the “auditory striatum,” and we have shown that this striatal region is important for auditory cue-based decision-
making and reinforcement learning. While it has been shown that auditory corticostriatal projections drive
auditory decision-making in rodents, it is unclear how established striatal neuromodulators including dopamine
influence these functions. Recent evidence indicates that neuromodulatory control and behavioral states play a
critical role in a wide variety of auditory behaviors. My preliminary pharmacological and tract-tracing data indicate
that dopamine, a key striatal neuromodulator, indeed plays a role in within the auditory striatum for auditory
decision-making. These data and previous literature contribute to my central hypothesis, which is that
dopaminergic signaling in the auditory striatum contributes to auditory decision-making by modulating striatal
sound representation. To address this hypothesis and to hone in on dopamine’s role, I propose two aims. First,
in Aim 1, I will monitor the activity of identified auditory striatum-projecting dopaminergic substantia nigra pars
compacta neurons through in vivo Ca2+ imaging and map these dynamics with respect to specific epochs of the
auditory decision-making task. Knowledge of how the activity of these dopamine neurons changes with respect
to decision-making behavior will allow me to infer how dopaminergic mechanisms modulate choice accuracy.
For instance, if DA activity corresponds to sound cue presentation, it may suggest that DA activity modulates
sound representation in the auditory striatum. In Aim 2, I will evaluate the importance of dopaminergic modulation
in the auditory task by optogenetically inhibiting dopaminergic projections during the same sets of defined epochs
of the auditory decision-making task evaluated in Aim 1. This will demonstrate whether dopamine is necessary
for mediating specific aspects of auditory decision-making, including sound cue representation. Overall, I will use
circuit-specific labeling, microendoscopic monitoring, and optogenetics in mice to investigate the role of
dopamine in auditory decision-making. Results from this study will advance understanding of how striatal
dopamine contributes to auditory perceptual decision-making, which in turn could bring new etiological insights
for auditory processing disorders and neuropsychiatric disease.

Public health relevance
Project Narrative The basic mechanisms of processing sound information in order to perform actions are poorly understood and are dysfunctional in a variety of brain disorders. I have found evidence to suggest that neuromodulatory dopamine signaling in the striatum may regulate this process. I will use circuit-specific labeling, calcium imaging, and optogenetics to dissect how dopamine signaling in the striatum affects auditory decision-making.